Mitigating Injury Disparities with Evidence Based Trauma Systems Planning

Traumatic injuries caused more than 200,000 deaths and the loss of 2 Million potential life years in the US in
2019. Black, Hispanic, rural, and low-income populations bear a disproportionate burden of injury incidence
and mortality. There is an increasing body of evidence suggesting systematic inequities in access to trauma
care are a substantial driver of these injury disparities, but current evidence does not identify or quantify
specific system-level interventions that might reduce health disparities. We propose the following aims to
identify strategies to mitigate disparities in trauma outcomes:
Aim 1: Examine approaches to trauma system planning in states without disparities in trauma
outcomes. We will conduct a series of in-depth case studies with a purposive sample of state trauma systems
(n=10) identified based on injury mortality trends from 2000-2020. Using document review and semi-structured
interviews with stakeholders responsible for trauma system planning in each state (e.g., medical directors,
nurse managers), we will examine the overall approach to trauma system planning, and specifically probe for
planning decisions intended to address disparities.
Aim 2: Identify modifiable trauma system characteristics associated with injury disparities and
decompose the structural pathways causing injury disparities. We will conduct a national survey of state
trauma systems to identify existing trauma system resources (e.g., infrastructure, personnel), then link survey
responses with outcomes data from the Centers for Disease Control and the Agency for Healthcare Research
and Quality. After identifying trauma system characteristics associated with injury outcomes among disparities
populations, we will use mediation pathway models to decompose the effects of trauma system resource
allocation as a determinant of injury disparities.
Aim 3: Identify and prioritize strategies to mitigate injury disparities through trauma system planning
and resource allocation. We will conduct a Delphi consensus panel with national stakeholders, in partnership
with the Coalition for National Trauma Research (CNTR). We will ask panelists to evaluate and prioritize
recommendations trauma system interventions to mitigate disparities, drawing from the results of Aims 1 and
2, and from the literature.
Impact of proposed work: Our proposed work will facilitate equity in trauma care by contextualizing current
approaches to trauma systems planning, identifying specific trauma care resources that mediate injury
disparities, and identifying actionable strategies to address disparities at the trauma system level. Our
partnerships with national trauma leaders will support dissemination and implementation throughout the US.

Public health relevance
Traumatic injuries caused more than 200,000 deaths and the loss of 2 Million potential life years in the US in 2019, disproportionately harming health disparities populations. There is an increasing body of evidence suggesting systematic inequities in access to trauma care are a substantial driver of injury disparities. We aim to identify system-level causes of injury disparities and develop recommendations for interventions to mitigate injury disparities.